SALSA - Study of Active Lifestyle Activation

PROJECT SUMMARY
The proposed supplemental funding request is in response to PA 20-272, and to support R01 CA263144
(SALSA: Study of Active LifeStyle Activation; NCT05075759; funding period 2021-2026). SALSA is a remotely
conducted 12-month randomized controlled trial testing a multi-faceted approach at improving physical activity
and diet quality in long-term survivors of childhood cancer at an increased risk of early cardiovascular (CV)
disease. The primary outcomes of the trial are reductions in sedentary time and improvements in diet quality
after 12 months. Secondary outcomes include other CV risk factors such as changes in blood pressure and
weight, and the measurement of various blood biomarkers known to be associated with CV disease (e.g., lipid
profile, insulin resistance, general inflammation, and adipokines). Collectively, many of these CV risk factors
may contribute to the phenotype of accelerated aging and premature frailty, which is now increasingly
recognized among cancer survivors, including survivors of childhood cancer. The proposed supplement seeks
to enhance our understanding of the accelerated aging phenotype in survivors of childhood cancer.
Specifically, we propose to approach SALSA participants who have completed the 12-month intervention with:
1) more in-depth phenotyping of physical function (via remote methods) beyond the actigraphy data collected
by the parent trial, and 2) collect additional biomarkers known to be associated with accelerated aging in
cancer survivors. Leveraging SALSA’s randomized trial design, we will also explore differences by study arms
(i.e., control group; clinician-led goal-setting; mHealth-based goal setting), and among those participants
(irrespective of study arm) who have better lifestyle profiles while adjusting for history of cardiotoxic cancer
treatment exposures. While the limited nature of this supplement may preclude our ability to identify statistically
significant differences between groups, it will provide important preliminary data demonstrating feasibility of
assessing physical function using remote methods, and data on potentially detectable differences that may
inform the design of future interventions that seek to target specific functional outcomes and other biomarkers
of frailty and accelerated aging.

Public health relevance
PROJECT NARRATIVE The proposed supplement to R01 CA263144 seeks to enhance data collection on the parent SALSA randomized trial by enabling the collection of detailed physical function assessments and genomic samples, and the processing of additional inflammatory biomarkers. These data can provide insight into the phenomena of accelerated aging and early frailty that has been increasingly recognized in long-term cancer survivors. This will then facilitate the development of future interventions that seek to improve physical function directly as a strategy to forestall frailty and potentially alter the aging trajectory in cancer survivors.